Oral Ciclopirox Treatment for Congenital Erythropoietic Porphyria.

ABSTRACT
To address the unmet need for an effective treatment for the ultra-rare porphyria, Congenital
Erythropoietic Porphyria (CEP), we propose a phase 1/2 clinical trial to be conducted by a team of porphyria
experts experienced in successful clinical trials for other porphyrias. CEP is an autosomal recessive inborn error
of heme biosynthesis resulting from mostly missense mutations that markedly reduce the activity of the heme
biosynthetic enzyme, uroporphyrinogen synthase (UROS), resulting in the massive accumulation of the non-
physiologic and phototoxic porphyrins, uroporphyrin and coproporphyrin I isomers. Pathophysiologically, the
pathogenic porphyrins accumulate in erythroid cells, leading to hemolysis, with the resultant severe clinical
manifestations of transfusion-dependency, splenomegaly, and phototoxic cutaneous blistering on sun-exposed
skin that often become infected, causing disfiguring photomutilation. Although bone marrow/hematopoietic stem
cell transplantation has been curative in transfusion-dependent children, the limitations of match, ablation
damage, graft rejection, graft vs. host disease, expert availability, etc. limit its use in clinical practice. Chronic
erythrocyte transfusions and iron chelation do not treat the underlying disease pathogenesis. Therefore, the
recent discovery of a pharmacologic chaperone, ciclopirox, previously FDA-approved as a topical fungicide, has
been modified for oral administration. This repurposed oral form, ciclopirox olamine, has been shown in in vitro
studies to increase the stability and activity of most known UROS missense mutations present in over 80% of
known CEP patients. In the knock-in murine CEP model, it increased residual enzymatic stability and activity,
thereby reducing accumulated porphyrins, splenomegaly, and cutaneous phototoxic damage. Importantly, this
oral drug would treat the pathogenesis of the disease as has been successfully accomplished with specific
chaperone therapies for Cystic Fibrosis and Fabry disease. A recent toxicity study in 34 normal adults found the
oral drug well tolerated. As the severity of CEP varies from hydrops fetalis to later-onset transfusion-independent
patients with severe phototoxicity, a phase 1/2 “N-of-1” study is proposed to evaluate the safety and efficacy in
adult patients. The proposed clinical trial involves a six-month run-in, a three-month open-label treatment period
with 2mg/kg of ciclopirox olamine, followed by nine months of 4mg/kg. As proof-of-concept endpoints, patients
will be evaluated to determine the drug's effect on blood hemoglobin levels and symptoms of anemia, sunlight
tolerance, porphyrins, hematologic measures including percentage of fluorocytes and reticulocytes, and quality
of life measures.

Public health relevance
PROJECT NARRATIVE Congenital erythropoietic porphyria (CEP) is an ultra-rare inborn error of heme biosynthesis resulting from the deficient, but not absent, activity of the enzyme uroporphyrinogen III synthase (UROS) which causes the accumulation of photoactive porphyrins in erythroid cells, resulting in hemolysis, severe transfusion-dependent anemia, splenomegaly, phototoxic cutaneous blistering and disfiguring lesions on sun-exposed skin. The objective of this phase 1/2 “N-of-1” clinical trial is to determine the safety and efficacy of a repurposed and orally- administered pharmacologic chaperone, ciclopirox olamine, to increase the residual UROS enzymatic activity, thereby decreasing the accumulated photoactive porphyrin substrates and their subsequent pathogenic effects. The efficacy of this trial will be based on improvement of anemia, increased sun tolerance, decreased pathologic porphyrin levels and peripheral blood fluorocytes, and quality of life improvements.